Yale/NIDA Neuroproteomics Center

We propose to continuously improve the Yale/NIDA Neuroproteomics Center that brings exceptionally
strong Yale programs in proteomics and signal transduction in the brain together with neuroscientists from 8
other institutions across the U.S. to create a national resource that will collaborate to identify adaptive changes
in protein signaling that occur in response to substances of abuse. Twenty-three faculty with established
records of highly innovative research into the molecular actions of psychoactive addictive drugs, as well as of
other basic aspects of neurobiology, will work together in a unique synergy with the Keck Foundation
Biotechnology Laboratory to create the Center, whose theme is “Proteomics of Altered Signaling in Addiction”.
The Center will use cutting edge proteomic technologies to analyze neuronal signal transduction mechanisms
and the adaptive changes in these processes that occur in response to drugs of abuse. With Co-Directors
Angus Nairn (Psychiatry) and Kenneth Williams (Mol. Biophys. & Biochem.) in the Administrative Core, the
Center includes Discovery Proteomics (DPC) and Targeted Proteomics (TPC) Cores. Biophysical technologies
from the DPC will extend protein profiling analyses into the functional domain while lipid analyses from the
DPC will leverage proteome level analyses to provide an increasingly biological systems level approach. A
Biostatistics and Bioinformatics Core (BBC) that includes high performance computing and the Bioinformatics
Support Program in the Yale Medical Library will provide essential support that will leverage the value of each
of the proteomic technology cores. A Pilot Research Project Core is a cornerstone in our efforts to encourage
strong mentoring relationships that will help attract and train future outstanding scientists.
Behavioral adaptations that accompany drug addiction are believed to result from both short and long-term
adaptive changes in brain reward centers. Thus, exposure to drugs of abuse regulates intracellular signaling
processes that alter gene expression, protein translation, and protein post-translational modifications.
Repeated exposure to drugs of abuse leads to stable alterations in these signaling systems that are critical for
the changes in brain chemistry and structure of the addicted brain. The Center's research goals include
analysis of the actions of cannabis, cocaine, nicotine, and opioids on these intracellular signaling pathways in
brain reward areas and development of methods that enable proteomic analysis of the single types of neurons
that define the circuits that underlie the actions and addictive properties of drugs of abuse. Targeted and data-
independent MS analyses of signaling proteins implicated in the actions of drugs of abuse will be used to
analyze the impact of substance abuse on the neuroproteome with motif-based, “Middle-down” MS/MS, and
other novel approaches being used to study protein post-translational modifications and to uncover the
interactomes of key proteins. A major initiative of the BBC will be to develop novel methods for deep
integration of genomic, transcriptomic, and proteomic data with brain region, cell type and allele-specificity.

Public health relevance
Project Narrative Drugs of abuse usurp and modify communication between different types of neurons within defined circuits in the brain, resulting in stable changes in the expression and activities of proteins (the “neuroproteome”) required for normal neuronal function. Improving our understanding of how drugs of abuse alter the distinct neuroproteomes of the specific neuronal sub-types that define the circuits that underlie the actions and addictive properties of drugs of abuse will provide deeper insight into the molecular basis of drug addiction and thus help in the design of new and more effective therapeutic strategies.